Ceramide and acute phase protein elevation during aging

Our lab has long standing interest in the mechanisms leading to the state of chronic, low-grade inflammation, which is an intrinsic component of the aging process and many aging-associated diseases. In the past we reported that the hepatic response to one of the major inflammatory cytokines, Interleukin 1β(IL-1β) is significantly augmented during aging causing an excessive production of IGFBP1, a secretory hepatic protein that binds to the Insulin-like Growth Factor 1 (IGF1) and neutralizes its bioactivity. This hyperresponsiveness is caused by intrinsic activation of neutral sphingomyelinase 2 in liver and accumulation of its product, ceramide, an evolutionary conserved second messenger, which mediates cellular stress response. Here we hypothesize that this IL- 1βhyperresponsiveness impairs the insulin signaling pathway in liver. First, we will investigate how aging-associated IL-1βhyperresponsiveness affects the insulin pathway and will study the interactions between key molecules in the two cascades PI3K, Akt-1, and Foxo1 (for insulin), and ceramide, IRAK-1 and JNK (for IL-1β). Studies will be done in isolated hepatocytes in vitro and in animals in vivo. Young, aged and aged calorie restricted rats and mice will be used. The regulation of IGFBP1 promoter by the two pathways will be investigated in H4IIE cells. These molecular studies will be complemented by assays of insulin- and IGFBP1-depndent functions in vivo, which include tests of IGF1 bioactivity, muscle functions and glucose regulation. Throughout the experiments cause and effect relations will be tested by overexpression and silencing approach using adenovirus-mediated gene transfer. Project

Public health relevance
Understanding the mechanisms that dysregulate liver functions during aging is very important for improving the health of older Americans, because liver plays critical role in the clearance of all prescription drugs, and the maintenance of overall body metabolism.